Deciphering the structural determinants of response and resistance to HER2-targeted antibody-drug conjugates and tyrosine kinase inhibitors for HER2-mutant Non-Small Cell Lung Cancer

Project Summary
HER2 activating mutations occur in approximately 3% of NSCLC patients and more than 20 other cancer types,
including breast and colon, comprising >10,000 patients annually in the U.S. More than 80 different recurrent
activating mutations are observed, and are distinct from HER2 amplifications. There are currently no FDA-
approved tyrosine kinase inhibitors (TKIs) for HER2 mutant cancers, and currently the only approved HER2-
targeted treatment for lung cancer is the antibody drug conjugate (ADC) trastuzumab deruxtecan (T-DXd). There
are two major obstacles limiting the effective use of HER2 targeted therapies for these patients. First, the different
mutations vary widely in their sensitivity to HER2 inhibitors, and there is no validated approach for selecting the
right HER2 inhibitor for a given mutation. Currently, trials typically select patients based on the exon in which the
mutation occurs (exon-based classification, e.g. exon 20-mutant NSCLC). These criteria, however, are not based
on biological evidence and we recently reported that even mutations within the same exon can vary widely in
terms of their impact on kinase structure and drug sensitivity. Second, tumors may acquire resistance either
through additional HER2 mutations (HER2-dependent resistance), or via HER2-independent mechanisms (e.g.
resistance to the ADC chemotherapy component such as deruxtecan, so called “payload resistance”). These
mechanisms are not yet well characterized, and we do not yet have a rational basis for selecting the most
appropriate drug for treating resistant tumors. In a recent publication in Nature, we reported that for a related
gene, EGFR, classifying mutations based on how they impact the 3-dimensional structure and drug response (a
structure/function-based system) more accurately predicted drug response than a standard exon-based
classification. We hypothesize that i) by using a similar structure/function-based approach, we could more
accurately match HER2 mutations with effective therapies than a standard exon-based approach, and ii) by
investigating HER2-dependent and -independent mechanisms of resistance, we can develop rational strategies
for targeting refractory tumors. To investigate these hypotheses, in Aim 1 we will comprehensively characterize
the landscape of HER2 mutations associated with response or resistance (both primary and acquired) to TKIs
using established preclinical models, including the LentiMutate scanning mutagenesis, and data from clinical
trials led by the MPI Dr. Heymach and others (see attached letters of support); in Aim 2 we will similarly
characterize the landscape of response and resistance for HER2-ADCs, and determine to what extent resistance
is HER2- vs payload-dependent. Finally, in Aim 3, we will develop a structure/function-based classification for
HER2 TKIs and ADCs and test strategies for targeting treatment-resistant tumors. The project brings together a
world-class team of investigators with expertise in HER2 biology, molecular modeling, and clinical trials for the
overarching goal of developing more tailored and effective approaches for HER2-mutant cancers.

Public health relevance
PROJECT NARRATIVE More than 10,000 patients annually in the U.S. are diagnosed with cancers harboring mutations in the HER2 oncogene, including ~3% of patients with non-small cell lung cancer (NSCLC), the leading cause of cancer mortality. There are more than 80 different recurrent HER2 mutations observed, and these mutations vary widely in their response to different therapies although there is currently no standard approach for classifying these mutations and matching them with the optimal therapy. Bringing together experts in HER2 signaling, molecular modeling, and clinical trials, we will develop a comprehensive, structure/function-based approach to more accurately match specific mutations with the most appropriate treatment, and characterize the different mechanisms by which tumors can become drug resistant as a foundation for more effective and tailored HER2 therapies.